Developing prototype injectability and developability testing system based on microfluidic quartz resonators

The objective of this SBIR Phase II proposal is to carry QATCH’s nanovisQ™ technology, which is a wide-
shear-rate range and low volume viscometer for determining developability and injectability of biopharmaceutical
formulations, from proof-of-concept to deployable, and reliable prototypes. This objective is motivated by the
needs of the growing protein-based biopharmaceutical therapeutics industry (with global market size over $100
billion). Protein-based therapeutics are administered as high concentration formulations due to the volume
constraints of subcutaneous injections. However, increased protein-protein interactions at these high
concentrations can cause injectability and manufacturability issues, which cannot be determined at early stages
of drug development due to the high sample volume requirements of conventional rheology techniques. By
developing a wide shear rate range, low volume viscometer, protein molecules can be optimized for
injectability/manufacturability and candidates with better developability can be selected for scaling-up. This
proposal is significant because the proposed device can assess injectability of protein formulations earlier in
drug development than existing technology and consequently reduce the time and cost of R&D spent in
developing new, injectable protein-based therapeutics considerably. In SBIR Phase I studies, QATCH has
successfully extended the shear-rate range of viscosity measurements of the nanovisQ™ for proper
characterization of the high concentration protein solutions. As a result, the nanovisQ™ is now positioned to be
a good fit for viscosity measurements of high concentration protein formulations. In SBIR Phase II QATCH is
proposing to 1) develop a sacrificial poly-Si based fabrication process to build microfluidics on quartz wafers,
2) develop a prototype control and data acquisition module for nanovisQ™ sensors. Developing deployable and
reliable nanovisQ™ sensors and instruments will be a key step in commercialization of this technology.

Public health relevance
Subcutaneous injections of protein-based therapeutics enable home administration and reduce the load on the healthcare facilities and healthcare costs. However, the injectability of protein-based formulations at the necessary high concentrations for injection cannot be determined at early stages of drug development due to a lack of material. Thus, protein molecules cannot be optimized or selected for injectability. Our technology addresses this by allowing the measurement of viscosity at shear-rate ranges relevant to injectability and manufacturability using very small volumes of formulations. This technology will enable prescreening and optimizing proteins for injectability during early stages of drug development and reduce the risk of scaling, and the associated costs, of uninjectable proteins. In the long-term, the availability of this technology is expected to increase the number of injectable protein-based therapeutics to address patients needs.